Novel nanoparticles to stimulate therapeutic angiogenesis in peripheral arterial disease

Abstract
The long-term goal of our parent grant award is to develop novel biocompatible and biodegradable dual-modal
imaging nanoparticles (DINPs) to provide cell protection and to facilitate therapeutic angiogenesis under stress
conditions such as ischemia for peripheral arterial disease (PAD). For this supplement application, we propose
the following approaches aimed to enrich the potential of our parent award: a) the development of fucoidan (FC)
targeted nanoparticles (FC-DINPs) with optimized fluorescent and photoacoustic imaging capabilities, b) the
formulation of FC-DINP loaded hydrogel angioplasty balloon coatings for simultaneous percutaneous
transluminal angioplasty and local drug delivery, and c) the evaluation of FC-DINPs transfer efficacy to ex-vivo
segments of porcine arteries. The main innovative aspects of our design are: 1) the simultaneous angioplasty
treatment and local delivery of therapeutic agents via a mussel-inspired nanocomposite balloon coating formed
by the combination of FC-DINPs and adhesive hydrogels, to ensure a homogeneous and controlled drug
delivery, 2) the use of biodegradable photoluminescent polymer-aniline tetramers (BPLPAT) to fabricate FC-
DINPs, 3) the use of fucoidan (FC), a high affinity targeting ligand for P-selectin overexpressed on injured
endothelium, to improve FC-DINPs attachment to the target site, and 4) the use of HA-DA, an adhesive hydrogel
synthesized with hyaluronic acid (HA) and dopamine (DA), to mimic the adhesive strategies of blue mussels and
to confer the characteristics needed to deliver FC-DINPs from the vehicle and gain adhesion to the inner blood
vessel wall. Furthermore, this proposal focuses on promoting diversity, equity, inclusion, and accessibility (DEIA).
Our proposed research approaches for the treatment of PAD are within the scope of the parent grant (“Novel
nanoparticles to stimulate therapeutic angiogenesis in peripheral arterial disease”) and will help to foster the
research career development of Ms. Ingrid D. Guerrero Rodriguez, a doctoral student from underrepresented
minorities (URM) with a disadvantaged background and a physical disability. She will be mentored and supported
by the PI, Dr. Kytai T. Nguyen, a researcher and educator with a proven record of her commitment to the
advancement of minority students in STEM.

Public health relevance
Narrative About 1 in every 100 Americans over 40 are affected by peripheral artery disease (PAD), a severe obstruction of normal blood flow in the legs. To overcome the limitations of current therapies, we propose to investigate new nanotechnology-based approaches: a) the development of fucoidan targeted nanoparticles with dual imaging capabilities, b) the hydrogels loaded with nanoparticles for local delivery via percutaneous transluminal angioplasty, c) the preliminary testing of our system using ex vivo models. This proposal is based on the parent grant “Novel nanoparticles to stimulate therapeutic angiogenesis in peripheral arterial disease” and aims to promote diversity, equity, inclusion, and accessibility (DEIA) by fostering the research career development of one underrepresented minority doctoral candidate.